Translating Research into Systemic Interventions for Tobacco Cessation

DESCRIPTION (provided by applicant): This is the final submission of an application for a K07 award for Dr. Dorie Apollonio, an Assistant Professor at the University of California, San Francisco, who is establishing herself as a new translational researcher. Her proposal focuses on efforts to use clinical research to support the creation of state policies mandating that smoking cessation therapy be available to ADM populations in treatment. This award will provide Dr. Apollonio with support necessary to achieve the goal of becoming an independent translational researcher experienced with all steps of the research translation process-clinical research generation, aggregation, and finally, its use by policy intermediaries-advocacy groups and journalists-who communicate these findings to policymakers. To achieve this goal, Dr. Apollonio has assembled a group of advisors including two primary mentors, Dr. Lisa Bero, Professor of Clinical Pharmacy, an expert in the creation of systematic reviews and in evidence-based medicine, and Dr. Ruth Malone, an expert in tobacco use in ADM populations. In addition, three co-mentors will provide expertise specific to each set of training activities and their associated aim; Dr. Neal Benowitz will share his knowledge of how clinical research is conducted, Dr. Daniel Dohan, will communicate his experience with qualitative research methods, and Dr. Laura Schmidt will provide training in developing behavioral interventions. In addition, she will work with four collaborators: Dr. Steven Schroeder and Dr. Joseph Guydish, who have been active with organizations seeking to implement smoking cessation therapy in mental health and substance abuse treatment centers, and Dr. Lisa Schwartz and Dr. Steven Woloshin, who have experience designing and evaluating educational interventions. Although clinical research often identifies effective public health interventions, many such interventions are not enacted into policy, leading to unnecessary death and disease. This problem is particularly acute in research on tobacco use, the leading preventable cause of cancer deaths in the United States, which disproportionately affects ADM populations. Dr. Apollonio's proposal will: (Aim 1) assess the correspondence between research evidence and popular understanding of smoking cessation therapy in ADM populations; (Aim 2) determine the means by which clinical researchers and policy intermediaries communicate scientific research findings; and (Aim 3) design, pilot test and evaluate web-based educational interventions to encourage better communication between policy intermediaries and clinical researchers. This research will form the basis for an R01 application to refine and study the effectiveness of educational interventions as a means of improving research translation.

Public health relevance
Public health relevance: Although clinical research often identifies effective public health interventions, many such interventions are not enacted into policy, leading to unnecessary death and disease. Improved understanding of how clinical research is communicated to policymakers is critical to making smoking cessation therapy the standard of care in ADM populations and to reducing the burden of tobacco-related disease in individuals already suffering significant health disparities. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Although clinical research often identifies effective public health interventions, many such interventions are not enacted into policy, leading to unnecessary death and disease. This problem is particularly acute in research on tobacco use, which causes 435,000 annual deaths in the United States and over 80% of all lung cancer deaths.(16) Approximately 200,000 of these deaths occur in alcohol, drug abuse and mental health (ADM) populations, where smoking rates are 2-4 times that of the general population.(17-19) Existing literature reports that smoking cessation therapy is effective in ADM populations, but only three states mandate that such therapy be made available in treatment facilities as a condition of licensure.(20, 21) Few studies attempt to identify how clinical research is translated into public health interventions or what encourages the enactment of such evidence-informed policy. Yet this knowledge is critical in ensuring that clinical research findings are used to save lives. Our long term goal is to increase the role of clinical research in developing public health policy interventions that address cancer risk. In pursuit of this goal, the overall objective of this application is to identify the role of clinical research in enacting state licensing and accreditation regulations mandating that smoking cessation therapy be made available to ADM populations in treatment. This research relies on findings that show journalists and advocacy groups play a critical information-gathering role for policymakers, serving as policy intermediaries. Our central hypothesis is that policy intermediaries and clinical researchers fail to communicate in ways that would encourage the translation of scientific findings into policy interventions. Our hypothesis has been formulated on the basis of preliminary data which suggest that (a) policy intermediaries want to use relevant clinical research findings and (b) clinical researchers want relevant findings to be enacted into policy, yet (c) policy intermediaries and clinical researchers have virtually no formalized relationships and their professional responsibilities do not include interacting with each other. An extensive literature identifies the limited use of scientific research by policy intermediaries, yet recent studies suggest that they seek to do better. The rationale for the proposed research is that by discovering how policy intermediaries and clinical researchers communicate, we can develop strategies to encourage research translation that will reduce tobacco-related disease in ADM populations, as well as other cancer risks. Our specific aims are: Aim 1. Assess the correspondence between research evidence and popular understanding of smoking cessation therapy in ADM populations. We will complete a systematic review of clinical research on the effectiveness of smoking cessation therapy for ADM populations in treatment. We will also conduct a content analysis of (a) related news and weblog stories archived on LexisNexis and (b) websites identified through common Google keyword searches. We hypothesize that clinical evidence shows smoking cessation therapy is effective in ADM populations, but that policy advocacy and popular reporting primarily rely on single sources and anecdotes rather than reviews of clinical evidence. Aim 2. Determine the means by which clinical researchers and policy intermediaries communicate scientific research findings. We will use focus groups to understand how ADM advocacy groups and science journalists identify and prioritize scientific research findings. We will also interview researchers that have published studies of smoking cessation therapy in ADM populations to identify the ways they have communicated their findings, and interview university public relations staff about their interactions with policy intermediaries. We hypothesize that policy intermediaries primarily rely on personal experience and have limited contact with clinical researchers, and that clinical researchers primarily communicate their findings to other researchers. Aim 3. Design, pilot test and evaluate web-based educational interventions to encourage better communication between policy intermediaries and clinical researchers. We will develop two web-based continuing education training modules, one targeted to policy intermediaries and one targeted to clinical researchers. Each intervention will identify the complement group's goals and uses of clinical research, provide information about organizations/conferences, and list their preferred communication strategies. A pilot follow-up survey will determine whether participants have contacted members of the complement group. We hypothesize that after the intervention, policy intermediaries will be more likely to initiate communication with clinical researchers. Our expected outcome is to gather preliminary data that will lead to an R01 application to refine and study the effectiveness of educational interventions in improving research translation. Although my doctoral and post- doctoral work makes me uniquely positioned to understand the public health policymaking process, support from a K award will allow me to obtain the training and mentoring I need to become an informed consumer of clinical research. Without such training, I would be unable to establish myself as an independent translational researcher experienced with all steps of the research translation process-clinical research generation, aggregation, and finally, its use by policy intermediaries and policymakers.